Task C13: Production and Distribution of Filarial Research Reagents

This contract provides for the development and standardization of nontraditional animal models of infectious diseases and may include candidate product efficacy testing, including GLP studies to support licensure.